Autophagy and the Replication of Hepatitis B Virus

Hepatitis B virus (HBV) is an important human pathogen that can cause severe liver diseases. There are
approximately 250 million people in the world that are chronically infected by this virus, resulting in nearly 1
million deaths every year. The current therapies for HBV patients do not generate sustained response in the
great majority of HBV patients. Thus, there is an urgent need of better treatments for HBV patients. This, however,
will require a better understanding of the life cycle of HBV for the identification of new therapeutic targets.
Autophagy is a catabolic process that is important for maintaining cellular homeostasis. Recent studies indicated
that HBV could induce autophagy to enhance its replication. By using cell cultures and transgenic mice that
carried the entire HBV genome, we previously demonstrated that autophagy was required for HBV DNA
replication both in vitro and in vivo. In our preliminary studies, we further discovered the association of DNA
replication-competent capsid particles with autophagosomes in hepatoma cells transfected with the HBV
genomic DNA. Interestingly, this association was not detected if the HBV core protein, which forms the viral
capsid, was expressed by itself. Our further analysis indicated that the HBV capsid particles were also associated
with phagophores, the membrane precursor of autophagosomes, regardless of whether the core protein was
expressed from the viral genome or by itself. These results, together with the previous reports that genes
essential for the formation of phagophores were required for the assembly of HBV capsid particles, indicated an
important role of autophagic membranes in HBV capsid particle assembly, maturation and trafficking. During this
grant period, we will continue these novel findings to further investigate the role of autophagy in the HBV life
cycle. Specifically, we will study the biological significance of the autophagosome-associated HBV nucleocapsids
and their possible role in the morphogenesis and egress of HBV particles, the role of phagophores in the
assembly of HBV capsid particles, and the mechanism that regulates the association of HBV nucleocapsids with
autophagosomes. These studies will provide important information for us to further understand the role of
autophagy in the HBV life cycle and facilitate the development of better treatments for HBV patients.

Public health relevance
PROJECT NARRATIVE Hepatitis B virus (HBV) is an important human pathogen that can cause severe liver diseases. There are an estimated 250 million HBV carriers in the world, resulting in nearly 1 million deaths every year. The current HBV treatments are less than satisfactory. The goal our proposed research is to understand the life cycle of HBV, which will be important for improving the treatments for HBV patients.